NRSA Training Core

PROJECT SUMMARY The University of Kentucky (UK) Center for Clinical and Translational Science (CCTS) Training Program in Clinical and Translational Science (UK TL1 program) will prepare professional and predoctoral students to assume leadership roles to direct team science across the clinical and translational research (CTR) spectrum. Over the last five years, the UK TL1 program has leveraged UK’s CTR strengths to provide a multidisciplinary and transdirectional training program that integrates trainees across diverse fields to provide a rigorous and solid research education in CTR. With this approach, we have achieved our goal of increasing the number of investigators who bridge the gap between basic science advances and their application to clinical medicine. This has been accomplished by providing a highly collaborative training environment that incubates scholars and mentors with an innovative and nurturing structure to develop research competencies in a team-­based environment. The success of trainees in the first funding cycle and the development of an innovative training process to engage even greater numbers of students in CTR are the foundation for the following Specific Aims: 1) to increase the pipeline of investigators engaged in CTR;? 2) to train across the spectrum of CTR;? and 3) to prepare scholars to participate effectively in team science. To meet our aims, we propose to increase the number of predoctoral TL1 students supported each year and to include a new 12-­month intensive CTR experience to meet an identified need among professional students and medical professionals in residency. We will continue to solicit applications broadly across campus, offer new experiential training in community research in rural populations in Central Appalachia, and develop doctoral-­level training in biomedical informatics, taking advantage of the recent influx of leadership and expertise in this area at UK. Finally, we will provide trainees with the latest skill sets to participate effectively in interdisciplinary and collaborative team science. These initiatives will accelerate the career development of future leaders of the biomedical research workforce who can address today’s complex research challenges and spearhead advances in human health.